Unraveling satellite glial cells dysfunctions in spiral ganglia of a mouse model of Fragile X syndrome

ABSTRACT
Sensory neurons convey information about external and internal environment to the brain. Proper function
of sensory neurons is regulated by different types of glial cells, and alterations in glial functions have
emerged as a major contributing factor in many neurodevelopmental disorders. While Schwann cells
surrounding sensory axons are very well studied, much less is known about satellite glial cells (SGCs), which
completely envelop sensory neuron soma in various sensory ganglia, including spiral ganglia mediating
transduction of sound. Spiral ganglia neurons in the cochlea receive auditory information from hair cells in the
ear and convey it to the brain with high speed and precision. Small alterations in conduction velocity in these
neurons have major effects on signal processing in the auditory circuits. Whether this peripheral auditory
system is dysregulated by FMRP loss remains largely unknown. Sensory deficits, and particularly
hypersensitivity to sound is one of the hallmarks of Fragile X syndrome (FXS) and other autism-spectrum
disorders. Increasing evidence suggests that sensory hypersensitivity in FXS leads to behavioral alterations
such as anxiety and impaired social interactions. The defects have been thus far largely attributed to sensory
processing abnormalities in brain circuits. However, core sensory and cognitive deficits may arise from an
earlier abnormality in sensory inputs that drive subsequent abnormal development of cortical circuits. Yet, the
mechanisms of sensory deficits in FXS remain poorly understood and no targeted treatments are available. In
response to this challenge, we began to define potential deficits in spiral ganglia neurons in Fmr1 KO mice,
the FXS mouse model. At the ultrastructural level, we observed altered association of spiral ganglia neurons
with their enveloping SGCs. We found that genes related to neural development and myelination are
dysregulated in Fmr1 KO spiral ganglia. We also observed abnormal number of immune cells in Fmr1 KO
spiral ganglia. Our initial observations point to potential deficits in the peripheral auditory system in FXS. The
goal of this proposal is thus to unravel the contribution of SGCs to sensory hypersensitivity caused by FMRP
loss. To achieve this goal, we will first determine if and how cell type proportions and the transcriptome of
cells in spiral ganglia are affected by loss of FMRP using single-cell RNAseq approaches at two critical
developmental stages, postnatal day 5 (P5, pre-hearing), P15 (post-hearing), and P28. We will also perform
electron microscopy analyses of spiral ganglia at the same stages to define the developmental timeline by
which SGCs envelop and myelinate spiral ganglia neuron soma in normal conditions and to identify when
abnormalities caused by FMRP loss arise during development. Finally, we will determine if absence of FMRP
causes alterations in the excitability of auditory neurons. These experiments will unravel potential defects in
peripheral auditory system in Fmr1 KO mice and provide the foundation for future in depth analyses and
hypothesis-driven approaches to ameliorate sensory hypersensitivity in FXS.

Public health relevance
PROJECT NARRATIVE Hypersensitivity to auditory stimuli is one of the hallmarks of Fragile X syndrome (FXS). Peripheral auditory neurons and their enveloping satellite glial cells in spiral ganglia form functional units that receive and transmit sound information, but whether functions of spiral ganglia neurons, satellite glial cells or other non-neuronal cells is disrupted and contribute to auditory hypersensitivity in FXS is not known. We propose to define the transcriptional and structural changes in spiral ganglia, and the defects in neuron excitability, with a potential to open new directions to ameliorate sensory deficits in FXS.